COVID-19. MAINTENANCE OF NIAID SPECIFIC PATHOGEN-FREE MACAQUE BREEDING COLONIES

Quarantine and testing of imported animals; support for animal care and breeding programs; upgrades to facilities and equipment to enhance monitoring and housing of animals and to protect health of animals and staff by reducing potential for SARS-CoV2 transmission and spread within the colonies.